NIGMS Program of Administrative Supplements to Support Undergraduate Summer Research Experiences (parent project: R35 GM130333)

Abstract
Interactions of proteins with other biomolecules regulate fundamental cellular events and misregulation of these
interactions leads to disease states. Proteins often utilize small, folded domains for recognition of other
biomolecules. The basic hypothesis guiding our research is that by mimicking these folded domains we can
specifically inhibit chosen complex formation with rationally designed synthetic molecules. Based on this
hypothesis, we have developed several classes of Protein Domain Mimics (PDMs) that faithfully reproduce
structural epitopes on protein surfaces. This work has created a foundation for the development of a new class
of structure– based therapeutics. Our efforts so far have focused on mimicry of a natural binding partner to
inhibit complex formation. A challenge with this approach is that natural protein-protein interactions are often
transient and characterized by weak binding affinities. Mimicry of one partner, therefore, often also leads to
weak binders, which are undesirable as inhibitors of complex pathways in the cellular context. A new approach
is, therefore, required for rational design of protein-based binders that does not begin with natural complexes.
In this NIGMS MIRA proposal, we aim to develop new starting points for PDM design by utilizing secondary and
tertiary structure-grafted protein displays for high affinity sequences. We will apply the new strategy to target
therapeutically important protein-protein interactions for which there are no potent inhibitors, including
intrinsically disordered proteins. Studies in each Aim will advance general approaches to inhibit protein-protein
interactions and establish PDMs as distinct constructs spanning the molecular size space between small
molecules and proteins.

Public health relevance
Project Narrative Protein-protein and protein-RNA interactions are vital for numerous biological processes, from cellular signaling to gene regulation, and their misregulation has been associated with a variety of diseases. Selective modulation of these interactions would, therefore, facilitate the discovery of candidate therapeutic agents for a broad range of diseases. The proposed research describes approaches for developing synthetic protein mimics for targeting chosen biomolecular complexes.